Plasmonic Inactivation of Virus and Mycoplasma Contaminants

SUMMARY
Biological pharmaceuticals, or “biologics”, are among the most important pharmaceuticals in development
today, and their safe manufacture is absolutely crucial for human health. A major problem faced by operators
of bioreactors, at both the laboratory scale and industrial scale, is microbial contamination as an integral risk of
any process that derives from live cell lines. The fundamental concern is to ensure that contaminated biologics
are not injected into the human body. To warrant contamination free biologics a terminal sterilization is often
necessary. The central challenge in this step is the inactivation or removal of microbial contaminates without
causing harm to the precious biologics. This work focuses on antibodies as representative biologics. Especially
for viral and mycoplasma contaminations the terminal sterilization step remains challenging due to the small
size of the pathogens. The industry standard today is removal through passive filtration using filter membranes
with pore diameters smaller or of the same size as the virus particles. This approach requires, however, long
processing times associated with high costs. Furthermore, ultrafiltration can induce antibody self-association
and is not compatible with emerging flexible, small-scale, point-of-care biologics fabrication technologies. The
need for new selective microbe inactivation strategies is also not limited to the field of biologics fabrication. The
Covid19 pandemic has recently illustrated the need for reliable virus inactivation strategies that selectively act
on the virus in tissues but not on proteins, for instance, to allow immunological assays of infected samples
outside of high containment laboratories. Light has sterilization properties, and UV-light has long been used to
inactivate a broad range of microbial pathogens. Unfortunately, it lacks specificity and also damages precious
biologics through reactive photochemistries driven by molecular absorptions in the UV range of the
electromagnetic spectrum. To overcome the shortcomings of both ultrafiltration and UV-irradiation as microbe
inactivation strategies, this proposal develops a plasmonically enhanced photonic inactivation method that
utilizes near-infrared (NIR) light for the selective inactivation of viruses and mycoplasma. As NIR radiation does
not overlap with molecular absorptions, the collateral damage on biologics is minimal. The proposed work will
reveal the fundamental working principles underlying plasmonic pathogen inactivation and implement magnetic
plasmonic nanoparticles (NPs) that allow for an easy, contact-free removal of the nanomaterials from the
samples after sterilization. The specific aims of this application are to:
Aim 1: Achieve Reliable Virus Inactivation with NIR Light through Plasmonic Enhancement
Aim 2: Demonstrate a Plasmon-Enhancement Strategy for Mycoplasma Inactivation with NIR Light
Aim 3: Demonstrate Scalable Clearance of Virus and Mycoplasma with Magnetic Plasmonic NPs

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Reinhard, Bjoern Plasmonic Inactivation of Virus and Mycoplasma Contaminants Relevance to Public Health Microbial contamination is a significant problem in the safe production of biologics as pharmaceuticals, and our goal is to develop nanoplasmonic materials that inactivate viruses and mycoplasma without harming the precious biologics. Biologics, in particular monoclonal antibodies, are among the fastest growing class of pharmaceuticals, and disruption of their production due to viral or mycoplasma contamination has the potential for profound impact on public health. Our approach combines new breakthroughs in the fields of plasmonic metamaterials and nanotechnology to address a vexing and persistent contamination problem in the safe production of monoclonal antibodies and other biologics. OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page